Isolating region specific α-syn-mediated mechanisms in mitochondrial function in vivo

Parkinson's disease (PD) is characterized by the loss of dopaminergic (DA) neurons and the accumulation of
Lewy Bodies (LB), but the underlying causative mechanism is unknown. So far, mutations in more than 8 genes,
implicated in many different cellular pathways are identified to cause familial PD (fPD). However, these genes
are also risk factors for sporadic PD (sPD), suggesting that both fPD and sPD could arise due to common patho-
logical mechanisms. Interestingly, while a plethora of mitochondrial processes are thought to be influenced by
mutant α-syn, the protein that is present in Lewy Bodies, fundamental questions still remain as to how normal,
unmutated α-syn contributes to mitochondrial homeostasis and how mutant, diseased α-syn cause mitochon-
drial dysfunction seen in PD. This is because several reports show contrasting/conflicting results depending on
the cell types used and the α-syn expression level tested. Therefore, to address this gap in knowledge what is
currently lacking is a cohesive strategy to successfully unravel the physiological from the pathological role of α-
syn in mitochondrial biology in vivo. The long-term goal of this proposal is to understand how α-syn-mediated
mitochondrial dysfunction contributes to PD at the resolution of a single mitochondrion in a whole organism.
The central hypothesis of this proposal is that particular regions of α-syn have critical roles in maintaining mi-
tochondrial homeostasis. Using transgenic animals containing N-terminal deletions or C-terminal PTM dele-
tions, two predictions will be tested: 1) the N-terminus of α-syn affects mitochondrial fragmentation pathways,
and 2) the C-terminus of α-syn affects mitochondrial damage/oxidation mechanisms. A unique strategy that
utilizes in vivo imaging and computation analysis of signal mitochondrion in a genetic model organism (Dro-
sophila) coupled with biochemistry will be employed. The rational is that once the a-syn-mediated roles on mi-
tochondrial biology are uncovered, innovative approaches to target effective therapeutics to maintain mitochon-
drial health can be initiated. Currently there are no cures for PD. Current FDA approved treatments only reduce
symptoms. This work has significant impact on isolating the region specific α-syn-mediated mechanisms on
mitochondrial biology, and obtaining knowledge on how a common pathway contributes to PD pathology, em-
phasizing a novel avenue for targeted therapeutics early before neuronal loss and clinical manifestation of both
fPD/sPD. This work is innovative as it represents a new/substantive departure from the status quo; the ap-
proach of isolating the physiological and pathological roles of a-syn in mitochondrial health in vivo, in an organ-
ism; highlighting a potential disease pathway for the clinical manifestation of not just PD, but also other synu-
cleinopathies, including stress induced TBI. The proposed research is significant, because it is expected to verti-
cally advance/expand current knowledge on how PD is initiated, considerably impacting current paradigms to
dramatically propel the development of novel modifiers against a-syn-mediated mitochondrial defects.

Public health relevance
Currently, there is an urgent need to understand the cause of Parkinson’s disease (PD): a devastating, hereditary, degenerative brain disorder for which there is no cure and only one FDA-approved treatment exists for symptomatic relief. The proposed research is relevant to public health because the discovery of how a-syn, the predominant protein involved in PD, affects mitochondrial health will dramatically propel investigations on targeting treatments against mitochondrial dysfunction. Thus, the proposed research is highly relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will enhance health, lengthen life, and reduce the burdens of trauma, illness and disability.